Factors Shaping the Genomic Spectrum of Structural Variants

PROJECT SUMMARY/ABSTRACT
Despite decades of research into mechanisms of double-strand break (DSB) repair, factors shaping the
outcomes of defective repair remain poorly understood. DSB repair plays a central role in the maintenance of
genome integrity, and is relevant for a variety of congenital diseases, cancer, and infertility. DSBs are repaired
by a range of mechanisms that utilize varying lengths of homologous sequence to form repair intermediates.
The mutations that occur when DSBs are joined to incorrect regions of the genome are termed structural
variants (SVs). I hypothesize that factors guiding SV formation and genomic patterns of SVs can be
revealed by studying features of SVs such as imperfect sequence homology, span, and SV type (ie
deletion, translocation, etc). Using innovative computational methods and experimentation in yeast and human
cells, I will test the following hypotheses:
Aim 1: Homology-mediated DSB repair uses imperfect homology to repair DSBs. My previous results
suggest that imperfect homology, or microhomeology (MHe) likely plays a role in homologous recombination
(HR). I will use computational methods to determine if HR status is associated with MHe prevalence across
thousands of genomes. I will then create DSBs in yeast and human cell lines to determine if DSBs are
preferentially repaired to regions with more homeology. Finally, I will analyze new datasets to determine if MHe
can be used as a tool to predict tumor response to drugs that target HR or cause DSBs.
Aim 2: Germline alterations in DSB repair genes associate with germline genomic signatures of SVs.
Using previously-established computational methods, I will discover patterns, or signatures, of SVs in large
databases of germline genomes. By comparing SV signatures between individuals with vs. without
loss-of-function mutations in DSB repair genes, I will determine the effect of DSB repair defects on genomic
structure. Finally, given recent surprising findings indicating a role for SVs in neurodegenerative disorders, I will
assess the role of SV signatures in heart and lung diseases. This work will enable greater understanding of
DSB repair, an essential aspect of cellular biology that plays a role in many areas of human health.
I plan to lead a lab leveraging wet and dry methods to study DSB repair, genomic signatures of SVs, and their
role in human disease. In my lab I will mentor young scientists, particularly those from underrepresented
groups. My career development plan includes training in software development, genomics tools, and yeast
experimentation, as well as scientific communication, lab management, and scientific writing. My institutions
provide a rich environment replete with ample seminars, cutting-edge technologies, and expert collaborators.

Public health relevance
PROJECT NARRATIVE Double strand breaks (DSBs) are a type of DNA damage that is relevant to congenital diseases such as Ataxia telangiectasia, Li Fraumeni syndrome, and Bloom syndrome, as well as cancer and infertility. Incorrect repair of DSBs result in a type of mutation called structural variants (SVs). I will study the impact of mutations in DSB repair genes on the types of SVs in human genomes, which will result in better understanding of mechanisms of DSB repair, and how defects in this repair shape the genome and affect human disease.